The Involvement of PBRM1 in Alveolar Macrophage Development, Homeostasis, and Immune Function

PROJECT SUMMARY
Pulmonary disorders like respiratory infections are one of the leading causes of death in the world and result in
millions of deaths annually. The immune system’s initial line of defense against lung disease are mononuclear
phagocytes called alveolar macrophages (AMs). These immune sentinels play an important role during
homeostasis by clearing foreign pathogens like microbes and toxins in the airways of the lungs via
phagocytosis. Additionally, AMs have an active role in pulmonary tissue repair by conducting efferocytosis, a
type of phagocytosis that specifically removes apoptotic cells. By preventing the release of proinflammatory
cytokines while secreting anti-inflammatory signals during efferocytosis, AMs contribute to barrier immunity and
exhibit an immunosuppressive phenotype. Studies have also demonstrated that AMs communicate
intercellularly with epithelial and T cells to prevent unneeded proinflammatory responses. Research into AM
development has shown that tissue-specific cytokines derived from the lungs, such as GM-CSF and TGF-β,
are required for the differentiation of monocytes into mature AMs. This plastic response to the pulmonary
microenvironment is regulated by epigenetic modifications, such as DNA methylation and transcription factor
recruitment. Notably, aberrant AM development and function have been implicated in the progression of
multiple lung malignancies, such as influenza infections, chronic obstructive pulmonary disease, and some
types of lung cancer. Furthermore, dysfunctional AMs can contribute to the increased morbidity and mortality of
elderly and immuno-compromised individuals. As such, this study’s long-term goal to enhance the
understanding of epigenetic mechanisms governing AM development and function tightly aligns with NIH’s
mission to prevent disease and improve human health. The key focus of this project aims to investigate the
role of PBRM1, the defining subunit of the SWI/SNF family PBAF complex, in dictating the development and
function of murine AMs. To elucidate the effects of PBRM1-deletion on AM development and phenotype, I plan
to 1) determine the requirement for PBRM1 in AM development and self-renewal, 2) determine the role of
PBRM1 in transcriptional and epigenetic programs of AMs by performing RNA-seq and ATAC-seq on PBRM1
WT and KO AMs to identify pathways and transcription factors which may be dependent on PBRM1, as well as
overlapping this data with CUT&RUN data of PBRM1 and transcription factors known to drive AM
development, such as PPARγ and PU.1.; and 3) determine the functional effects of myeloid-specific PBRM1
deletion during influenza infection. These studies will assess the epigenetic and transcriptional effects of
PBRM1-loss in AMs and provide evidence for novel co-regulators of PBRM1. In the future, this research will
serve to inform the development of targeted therapies of PBRM1-dependent processes affecting lung disease.

Public health relevance
PROJECT NARRATIVE As respiratory infections result in millions of deaths annually, these pulmonary diseases are considered as the global leading cause of communicable mortality. As such, human health greatly benefits from studies that address the regulatory mechanisms of immune development and function in the lungs. This research proposal aims to investigate the regulatory contributions of chromatin remodeling during the development, maintenance, and immune response of alveolar macrophages to respiratory infections.